Cancer Control Research Program

PROJECT SUMMARY: CANCER CONTROL RESEARCH PROGRAM
The Cancer Control (CC) Research Program at the Sylvester Comprehensive Cancer Center (Sylvester) is co-
led by Frank J. Penedo, PhD, and Erin N. Kobetz, PhD, MPH. This program advances the science of cancer
control, particularly for the diverse communities comprising South Florida, Sylvester’s catchment area. This
endeavor strategically aligns with the program’s two specific aims: 1) Identify and characterize multilevel
determinants of cancer etiology, risk, and outcomes from prevention to survivorship among diverse
populations; and 2) Design and test innovative interventions to reduce cancer disparities and improve
outcomes along the cancer control continuum (i.e., from prevention to survivorship and end of life). Since 2014,
with significant Sylvester investment, the CC program has steadily grown in membership and scientific
productivity. CC now includes 29 members from three University of Miami Colleges and Schools (Medicine,
Arts and Sciences, and Communications) representing ten departments. CC program members have secured
nearly $6.2M in annual direct peer-reviewed, cancer-related extramural funding, of which approximately one
third is awarded by the National Cancer Institute. Since 2014, program members published 251 peer-reviewed,
cancer-relevant publications, with strong evidence of program-initiated collaborations (28% intra-programmatic
and 27% inter-programmatic); 63% of CC program publications occurred via collaborations with other
institutions. Members have made key contributions in improving cancer screening and survivorship in diverse,
medically underserved communities. Much, if not all, of this work has direct relevance to Sylvester’s catchment
area, as evidenced by program members’ use of participatory research and psychosocial oncology
methodologies, focus on locally prevalent cancers, and commitment to culturally grounded intervention design
and delivery. Guided by its 2014-2018 Strategic Plan, Sylvester has further invested in and cultivated the
development of key supporting research infrastructure for its cancer control efforts, most notably the
Behavioral and Community-Based Research Shared Resource and Sylvester’s Office of Outreach and
Engagement, which are fully aligned to support the CC program aims. These resources provide necessary
platforms for ongoing dialogue between program members and diverse stakeholders. The program will
capitalize on this infrastructure for future growth as well as pursue targeted recruitment of faculty with expertise
in cancer epidemiology, health services research, and cancer survivorship, while strengthening the
crosscutting, thematic emphasis on health disparities among vulnerable racial, ethnic, occupational, and aging
populations that comprise South Florida.